Developing Pediatric Endocrinologist for the Future

Project Summary / Abstract:
This application is a proposal for a Fellowship training program in pediatric endocrinology, designed to provide
multidisciplinary training in diabetes research at The Barbara Davis Center (BDC), and the Children’s Hospital
Colorado (CHC) at the University of Colorado Anschutz Medical Campus (CU AMC). It also proposes to train
post-doctoral psychologists in diabetes behavioral research. Funding is requested for two years of research
training for three Pediatric Endocrinology trainees and one PhD psychologist in each year of the Program as
well as 3 Summer Medical Students (Short-term Scholars Program). The proposal’s rationale is: 1) There is
a critical shortage of pediatric endocrinologists and psychologists trained in diabetes research 2) Diabetes is
an increasingly significant healthcare problem in the pediatric population with devastating consequences from
a personal and health economics viewpoint 3) Current rapid advances in diabetes investigation calls for an
increased pool of physician scientists trained in clinical, biochemical, epidemiological, and behavioral research
to carry out basic and translational research in pediatric type 1 (T1D) and type 2 diabetes (T2D) to bring
advances in diabetes research to the clinical arena. Psychologists training in behavioral research beside
physicians will add strength to the physician program and contribute diabetes research trained psychologists
to the very small pool of these important specialists. The BDC and CHC have an extensive and proven record
in research training of young investigators. A strong endocrinology program at CHC, in addition to a research
program in T2D, will provide a well-rounded pediatric endocrinology training program. The BDC, CHC and the
wider CU AMC have well-established investigators in the epidemiology, pathophysiology, immunobiology,
genetics, and molecular biology of T1D and T2D. This network of experienced mentors is ideally suited to
develop the next generation of young pediatric endocrinologists prepared for a career as diabetes
investigators. Areas of research focus within the BDC include developmental islet cell biology, genetics,
immunology, autoimmunity, prediction and prevention of T1D, as well as the epidemiology of and novel
treatments for T1D and T2D. The integration of psychologists training in diabetes behavioral research will add
importance and depth to the Program. These areas of research are urgently needed and have been identified
as important to the national public health to address diabetes in the US. This application is enhanced and
supported by Colorado Clinical and Translational Research Institute, the Pediatric Clinical Translational
Research Center, the CU Diabetes Research Center, the Departments of Pediatrics, Medicine and the
Colorado School of Public Health. The ability to provide strong didactic courses in statistics, epidemiology,
research methods, ethics and regulation of human research, medical writing, molecular biology and genetics,
combined with a strong mentoring faculty will allow us to provide the training required to develop pediatric
endocrinologists and psychologists into the scientists needed for the leaders of tomorrow.

Public health relevance
Project Narrative Our NIDDK T32 Training Program “Developing Pediatric Endocrinologists and Diabetes Psychologists for the Future” will be conducted at the Barbara Davis Center for Childhood Diabetes, University of Colorado School of Medicine and Children’s Hospital Colorado, Anschutz Medical Campus. Our PRINCIPAL OBJECTIVE is to develop Pediatric Endocrinologists and Psychologists who are well grounded in basic and/or translational science research skills required for advancing the field of knowledge in type 1 and type 2 diabetes and are educated in collaborative and integrated approaches for translating basic discoveries in diabetes into opportunities for advancing clinical research and care. Our OVERALL GOAL is that after their training, our trainees will have acquired the professional skills to become clinician scientists beginning productive academic careers as junior faculty investigators who will have the leadership capacity to make significant impacts in the fields of type 1 and type 2 diabetes in children and adolescents.